Pericyte and Extracellular Matrix Dysfunction in Thoracic Aortic Aneurysm

Project Summary/Abstract
A thoracic aortic aneurysm is a disease process that involves dilation of the vessel caused by a weakening of its
wall. This dilation of the aorta has the potential to lead to rupture and death unless treated with a dramatic
surgical intervention to replace the diseased aorta. Indications for surgery largely rely on size and often fail to
capture all of those at risk for rupture and death. While various theories have been put forward, the molecular
and biomechanical causes of aortic wall weakening have not been elucidated. Consequently, novel therapies to
prevent or reverse this disease process have not been produced.
The aortic wall consists of three layers identified as the intima, media, and adventitia. In aortic aneurysm, smooth
muscle cell death and elastin fiber fragmentation is typically observed in a process termed cystic medial
degeneration. While many studies have previously focused on the aortic media, recent work has placed focus
on the outer layer of the aorta. The aortic adventitia contains numerous small blood vessels known as vasa
vasorum which provide blood flow to the outer half of the aortic wall. The vasa vasorum are made up of
endothelial cells and supportive pericytes which regulate flow through these vessels. A recent study in our lab
has revealed deficient and dysfunctional vasa vasorum in aneurysmal human aorta. Hypoxia in the outer half of
the aorta and a decrease in growth factors associated with blood vessel formation were also observed. Based
on this knowledge, we posit that a reduction in perfusion from vasa vasorum dysfunction leads to hypoxia and
subsequent aortic wall weakening. This study aims to examine this disease process at the level of the pericytes
which support the vasa vasorum. Preliminary findings have revealed that human aortic aneurysm-derived
pericytes involved in the formation and maturation of vasa vasorum are dysfunctional. In addition, extracellular
matrix (ECM) from human aneurysmal aortic tissue produces deleterious effects on normal aortic pericytes and
endothelial cells. Given these findings, we hypothesize that aortic aneurysm arises from dysfunction in the cells
and extracellular matrix that contribute to vasa vasorum formation.
Specific Aim 1: Compare function of vasa vasorum pericytes and human adventitial ECM from aneurysmal and
normal aortic tissue
Specific Aim 2: Investigate therapeutic applications of porcine ECM in rabbit aneurysm model
Through this study, we seek to identify targets for novel therapeutic biomaterials such as porcine extracellular
matrix hydrogel. Our long-term goal of this project is to improve identification of those at risk for aortic dissection
or rupture and to provide less-invasive treatment modalities that prevent the sequelae of thoracic aortic disease.

Public health relevance
Project Narrative Thoracic aortic aneurysm is a disease process involving degenerative dilation of the aorta leading to eventual rupture and death unless treated with complex surgical intervention. The proposed work aims to delineate the pathogenesis of aortic aneurysm at the cellular level while also exploring the pro-regenerative properties of extracellular matrix hydrogel in an animal model. Our ultimate goal of this research is to improve screening and surveillance of this patient population while also investigating potential regenerative therapies that halt the process of aneurysm formation.